Behavioral Shifts in Dementia Patients Using Novel Pharmacy Home Robotics: A Cost-Effective Approach to Aging in Place

Project Summary
Over 7 million Americans aged 65 and older are living with Dementia, making it a leading cause of dependence
and disability. Alzheimer's Disease and Alzheimer's Disease Related Dementias (AD/ADRD) remain a public
health crisis stemming from behavioral and psychological symptoms that have to be managed directly by
caregivers. Patients with AD/ADRD ($287,038) are the most expensive chronic conditions to manage, with
costs often exceeding those of cancer ($173,383) or heart disease ($175,136). Poor medication adherence
contributes to high rates of hospitalizations, caregiver burden, and significant reductions in one's quality of life
(QoL). The home environment standard of care for caregivers varies greatly; currently, medication
management devices are contra-indicated for AD/ADRD use. Current medication adherence rates for
AD/ADRD are estimated to be ~17-42%, and medication behaviors remain challenging to track.
HiDO Tech developed HomeCare, an internet-connected self-medicating device integrated with a novel
Pharmacy Distribution System (PDS) to address these gaps. The PDS ensures a secure chain of custody for
medications, from delivery by a licensed mail-order pharmacy to administration by HomeCare, which uses
Video Direct Observed Therapy (VDOT) to monitor consumption and alert caregivers to deviations. In a phase
I SBIR R43AG077737, HiDO Tech demonstrated the feasibility and usability of HomeCare with AD/ADRD, and
in a Medicare Advantage pilot study, HomeCare successfully altered patient medication behaviors, improving
QoL, which decreased hospitalizations by 80% and lowered the cost of care by 67%.
In Phase II, HiDO Tech will conduct a two-arm randomized controlled trial to validate the HomeCare and PDS
system's ability to improve adherence, cognitive outcomes, and caregiver support for persons with Dementia
(PwD).
Primary Outcomes: Medication adherence will be tracked through automated logs in the HomeCare arm and
self-reported logs in the standard care arm. Cognitive function will be assessed using the ECog at baseline, six
months, and 12 months. Hospitalization rates will be measured quarterly via EMR reviews.
Secondary Outcomes: Caregiver burden will be evaluated through task logs and surveys, while satisfaction
and usability will be assessed using standardized metrics like NPS. Correlations between adherence
improvements and reduced hospitalizations will also be analyzed.
Exploratory Outcomes: QoL for patients and caregivers will be measured using DEMQOL and Zarit Burden
tools. Caregiver-patient engagement will be explored through interviews, surveys, and activity logs.
Impact: HomeCare with integrated PDS offers a transformative solution for AD/ADRD care by reducing
hospitalizations, stabilizing chronic conditions, improving QoL, and alleviating caregiver burden. This low-cost
device bridges critical gaps in dementia care, driving innovation and cost-effectiveness.

Public health relevance
Narrative This research focuses on the escalating crisis of Alzheimer's disease and related dementias (AD/ADRD), which disproportionately impacts families, with the number of persons with dementia (PwD) expected to double by 2060, leading to increased healthcare costs and caregiver burdens. The study integrates HomeCare, an internet-connected robotic caregiver, with an integrated Pharmacy Distribution System (PDS) designed to transform current medication management practices for PwD at home. By ensuring a seamless chain of custody from pharmacy delivery to medication administration, HomeCare and the PDS work together to improve adherence behaviors, monitor health changes, and provide timely alerts to caregivers, a comprehensive approach that aims to reduce hospitalizations, lower healthcare costs, enhance quality of life (QoL) for patients, and alleviate caregiver burden.